FLUORESCENCE MICROSCOPE TO LOOK AT DETHIEON OF MOLECULES IN CONGINED GEOMETRIES

Trying out prelimnary feasibility of using fluorescence microscope to understand dethieon of molecules in congined geometries.